The dynamic interplay of human cells and Entamoeba histolytica during trogocytosis (cell-nibbling)

Abstract
Entamoeba histolytica is a pathogenic amoeba and the causative agent of amoebiasis in humans.
Despite its impact on human health, E. histolytica is dramatically understudied. The species name (histo-: tissue;
lytic-: dissolving) derives from the ability to destroy host tissues. E. histolytica trophozoites (“amoebae”) invade
the large intestine, causing ulceration and can enter the bloodstream, and they can disseminate to disseminate
to other tissues, causing fatal abscesses. Little is known of the mechanisms that allow E. histolytica to damage
the intestine. We established a new paradigm by discovering that amoebae attack and kill human cells by biting
off and ingesting human cell fragments, which we named “amoebic trogocytosis” (trogo-: nibble) (Ralston, et al.,
Nature, 2014). Since trogocytosis occurs in many other eukaryotes, this process may be fundamental to
eukaryotic cell biology. However, the mechanistic differences between eukaryotic trogocytosis and phagocytosis
(ingestion of entire cells) are unclear, as are the signals that initiate each process. When amoebae are
incubated with live human cells, they take bites, but when amoebae are incubated with dead human
cells, they eat the entire cells. This suggests that either live human cells play an active role in trogocytosis, or
that physical properties of live cells, such as deformability, are necessary. Building on the discovery of
amoebic trogocytosis, we propose to further delineate the interplay between the amoeba and human
cell, and what about this interplay leads the amoeba to perform trogocytosis vs. phagocytosis. Beyond
E. histolytica, trogocytosis is a burgeoning theme with has far-reaching applications to eukaryotic biology.
Several microbes use trogocytosis to kill other cells, including the “brain-eating” amoeba Naegleria fowleri. In
multicellular eukaryotes, trogocytosis is used for cell-killing, cell-cell communication and cell-cell remodeling, and
it plays roles in the immune system, the central nervous system, and during development. An improved
understanding of the mechanism and biology of E. histolytica trogocytosis will apply both directly to the
pathogenesis of amoebiasis and broadly to eukaryotic trogocytosis in general. This work is significant and
high-impact as it will improve understanding of trogocytosis, a process that is changing the paradigm
for amoebiasis pathogenesis. New understanding of the interplay between cells during trogocytosis will
also apply broadly to eukaryotic trogocytosis in general.

Public health relevance
Project Narrative Entamoeba histolytica is the causative agent of amoebiasis in humans, and its abilities to kill human cells is likely to drive its capacity to invade and damage host tissues. We established a new paradigm by discovering that amoebae kill human cells by biting off and ingesting fragments, which we named “amoebic trogocytosis” (trogo-: nibble). Building on this discovery, here we propose to delineate the interplay between the amoeba and the human cell, and what triggers the amoeba to perform trogocytosis, which will apply both directly to the pathogenesis of amoebiasis and broadly to eukaryotic trogocytosis in general.